Utilizing phylodynamic and causal artificial intelligence methods for predicting and characterizing antibiotic resistant bacterial transmission within and beyond hospital settings

PROJECT SUMMARY/ABSTRACT
Antimicrobial resistance (AMR), particularly in the context of hospital-acquired infections, poses a significant
global challenge. It increases morbidity, mortality, healthcare costs, complicates infection control measures, and
undermines the effectiveness of existing antimicrobial treatments. This proposal is designed to address the
complexity of AMR transmission patterns, which have remained uncertain under traditional outbreak
management strategies. Therefore, novel data-driven approaches are urgently needed, leveraging modern
genomic and computational methods for a better understanding and control of AMR pathogens. The proposal's
overarching objective is to provide a high-resolution characterization of multi-drug resistant (MDR) bacterial
transmission patterns and evolution within and beyond hospitals. The project will integrate complex data sources,
such as whole-genome sequencing (WGS), electronic health records (EHR) and epidemiologic data from a
prospective cohort study, and then apply phylodynamic and causal artificial intelligence methodologies to
achieve these goals. It focuses on two specific aims. The first will be to characterize flow of transmission from
communities to hospitals in gram-negative MDR bacterial infections. The application of WGS, linked with
sociodemographic and economic data, will be used to trace the lineages of these bacterial infections. Based on
preliminary work on gram-positive MDR pathogens, we expect the majority of gram-negative hospital-onset
infections originate from community ancestral strains rather than within the hospital setting, pointing towards
independent introductions of bacterial strains into the hospital setting. The second aim will identify use EHR and
causal artificial intelligence to develop a causal model that predicts WGS-confirmed MDR bacterial outbreaks
with higher precision than conventional approaches. This aim will identify actionable within-hospital factors that
increase the risk of MDR bacterial outbreaks. By addressing a critical gap in the interplay between hospital and
community settings in the transmission of MDR bacterial strains, the outcomes of this study are expected to
contribute to a potential shift in how infection control teams utilize existing data sources. Ultimately, this project
will provide the trainee with the expertise in using complex data to understand the evolution of emerging
pathogens and identify mechanism of transmission in hospitals. The skills cultivated from this project will enable
the trainee to pursue his long-term career goal in becoming an infectious disease physician-scientist with the
unique ability to integrate molecular biology, hospital epidemiology, and modern data science approaches. This
research and training directly target the need for innovative data science to inform tailored interventions to
combat AMR, especially among gram-negative pathogens.

Public health relevance
PROJECT NARRATIVE This project aims to confront the global challenge of antimicrobial resistance by employing modern genomic and computational approaches to trace and understand multi-drug resistant bacterial transmission patterns. The integration of complex data from sources such as whole-genome sequencing and electronic health records, will enable high-resolution characterization of bacterial evolution and flow both within and beyond hospital settings. The findings from this project will contribute to the transformation of infection control teams by informing the design of actionable interventions to control hospital-onset outbreaks due to these emerging bacterial pathogens.